Developing models of placenta-driven developmental lung injury in human preeclampsia

PROJECT SUMMARY
The following proposal is a 5-year career development and training plan that will prepare Dr. Taglauer for a
career as an independent clinician-scientist and leader in the field of neonatal lung disease. The chronic lung
disease of prematurity, (i.e. bronchopulmonary dysplasia) causes significant impairment to the short-term and
long-term health of neonates. To date, most studies on bronchopulmonary dysplasia (BPD) pathogenesis have
focused on postnatal lung injury. However, the antenatal determinants predisposing infants to BPD have been
less well-defined. Among these, the pregnancy disease of preeclampsia has a strong clinical association with
BPD. Multiple studies have identified that premature infants born to mothers with preeclampsia have a
significant risk of developing BPD postnatally. The primary source of preeclamptic disease is the placenta. In
preeclampsia, placental dysregulation causes the release of anti-angiogenic and proinflammatory factors. Dr.
Taglauer’s long term research goal is to characterize and address developmental lung injury caused by human
preeclampsia. Dr. Taglauer has previously identified in a rodent model of experimental preeclampsia that pups
born to preeclamptic mothers have changes in lung morphology and alterations in key developmental gene
expression. During her K08 award period, Dr. Taglauer will expand upon these findings by evaluating the
influence of human preeclampsia on fetal lung development. Dr. Taglauer will test the hypothesis that the
human preeclamptic placenta releases pro-inflammatory and anti-angiogenic signaling proteins into the fetal
compartment that cause specific injury to alveolar epithelium and pulmonary vasculature. Specifically, she will
1) identify human preeclampsia-specific placental proteins in the fetal circulation involved in lung
developmental injury pathways; 2) develop an in vitro model to evaluate the impact of human preeclamptic
placental proteins on human alveolar epithelial and pulmonary vascular endothelial cells; and 3) establish an in
vivo rat pregnancy model to examine the effect of human preeclamptic placental proteins on postnatal lung
development. Dr. Taglauer has 75% protected research time from the Department of Pediatrics at Boston
Medical Center to accomplish these project aims under the guidance of co-mentors Dr. Darrell Kotton at the
Center for Regenerative Medicine at Boston University/Boston Medical Center and Dr. Steve Abman at the
University of Colorado School of Medicine. She has assembled an excellent scientific advisory committee with
diverse expertise to guide her scientific research and career development. Dr. Taglauer has also created a
comprehensive training plan that includes mentored research in the Kotton and Abman labs, didactic
coursework, presentations at national scientific meetings, manuscript preparation and acquisition of additional
grant funding leading to an R01. Dr. Taglauer has the strong commitment from her institution to accomplish
these goals and transition to an independently funded physician scientist by the end of this award.

Public health relevance
PROJECT NARRATIVE The neonatal lung disease of bronchopulmonary dysplasia (BPD) is associated with significant morbidity and mortality that still impacts neonates worldwide despite decades of research. BPD risk is significantly associated with the pregnancy disease of preeclampsia but the mechanisms driving this association have not been well-defined. Preeclampsia is uniquely human disease caused by placental dysregulation leading to the release of anti-angiogenic and proinflammatory factors which have the potential to circulate into the fetal compartment and cause harm to the developing fetal lung. This proposal leverages a novel approach of incorporating human placental components into lung developmental model systems to define mechanisms of human preeclamptic developmental lung injury.